Functions of mRNPs in RNA metabolism in Plasmodium falciparum

PROJECT SUMMARY
The emergence of resistance to frontline therapies in the malaria parasite underscores the pressing need for
sustained drug discovery and development efforts. Protein translation is largely unexplored in malaria parasites,
yet recent studies highlight the translation machinery as a promising target for novel antimalarial drugs. Our
work on the DDX6-family RNA helicase DOZI has uncovered that the human malaria parasite Plasmodium
falciparum utilizes different membrane-less cytoplasmic messenger ribonucleoprotein (mRNP) granules to
control protein translation. These granules, akin to processing bodies, stress granules, and germ cell granules
in model eukaryotes, orchestrate various mRNA metabolism functions, encompassing RNA decay, storage,
and translation repression. Building upon these findings, we posit that distinct mRNP types play pivotal roles in
global and transcript-specific mRNA regulation, governing parasite development, life stage transitions, and
survival under stress. To elucidate these regulatory mechanisms, we employ cutting-edge techniques in
reverse genetics, protein biochemistry, microscopy, transcriptomics, and proteomics. Our first objective is to
identify molecular markers for distinct mRNPs, determine their protein and mRNA compositions, and
characterize their dynamics across different parasite life stages and under stress conditions. Secondly, we will
delve into the functions of key RNA-binding proteins within the mRNP granules, deciphering their roles in
regulating mRNA stability, decay, and translatability. While these aims are sufficiently independent to be
carried out in parallel, their intermediate results will mutually inform and reinforce one another, augmenting the
overall significance and feasibility of the study. Collectively, the insights gained from these objectives will
contribute to a comprehensive understanding of the diverse roles of mRNPs in regulating critical aspects of P.
falciparum biology, laying the groundwork for discovering new antimalarial drugs.

Public health relevance
Project Narrative In malaria parasites, protein translation is critically regulated during development and responses to stress conditions. This proposal aims to understand how malaria parasites control mRNA metabolism globally and specifically to orchestrate parasite development during host transitions and after exposure to stress conditions.